Structure and dynamics of G protein coupled receptor-G protein complexes

Project Summary
G protein-coupled receptors are important conduits to relay extracellular signals to
downstream intracellular signal transduction pathways. Their central role in intercellular
communication together with the shear magnitude of the gene family (>800 genes) have therefore
made GPCRs superb therapeutic targets. Understanding the mechanism of hormone action on
GPCRs and understanding how drugs modulate their behavior is an important fundamental endeavor
but also an important mission for health scientists. The primary goal of this ongoing research
program is to study the mechanism of GPCR regulation of their primary signaling partners, G
proteins. In this renewal we will use biochemical and biophysical approaches to delineate the
mechanism of GPCR·G protein (R·G) interactions to try to resolve the extraordinary selectivity of G
protein isoforms for specific members of the GPCR superfamily. We will focus on a narrow but
representative collection of GPCRs (b2AR, M2 & M3AChR, µOR and NTSR1) and their coupling to
different G protein isoforms (Gs, Gi/o, Gq/11 and G12/13). Our major goal is to gain insight into the
structural and dynamic bases underlying R·G specificity by determining how these family members
couple to and activate specific G protein isoforms. In the previous funding cycle we made several
breakthroughs by solving the structures of 6 different R·G complexes: µ opioid receptor (µOR)·Gi1,
neurotensin receptor subtype 1 (NTSR1)·Gi1, cannabinoid receptor subtype 1 (CB1)·Gi1, muscarinic
M2AChR·GoA, muscarinic M1AChR·G11, and glucagon receptor (GCGR)·Gs. These structures
reveal key regions on the receptors and G proteins that we suspect confers receptor and G protein
isoform selectivity. In this renewal we propose to apply a spectrum of biochemical and biophysical
approaches to interrogate the interaction sites revealed in the R·G structures. In addition, our recent
studies suggests various conformational states of the R·G complex, strongly suggesting the existence
of intermediate states. In this renewal we propose to examine these intermediate states and probe
their potential to contribute toward R·G specificity, and toward receptor-catalyzed nucleotide
exchange. We will utilize cutting-edge approaches including cryo-electron microscopy (CryoEM),
double electron-electron resonance (DEER) spectroscopy, fluorescence resonance energy transfer
(FRET), single molecule spectroscopy (SMS) and interferometry to study these R-G interactions. We
will study the nature of the R-G specificity, whether the underlying mechanism may be at the pre-
association (perhaps through an intermediate state), or at the coupling stage. We feel that with our
expertise, the generation of innovative reagents, the incorporation of cutting edge biophysical
approaches and the generation of strong preliminary data together make this proposal tractable.

Public health relevance
Project Narrative (significance) G protein-coupled receptors (GPCRs) represent the largest superfamily of membrane proteins in the human genome and their critical role in physiology has made GPCRs excellent targets for therapeutics. The goal of this proposal is to determine how GPCRs activate specific G proteins in response to hormones and neurotransmitters, and modify the function of cells. This information will be extremely helpful for the discovery of drugs for the treatment of several diseases including: cardiovascular disease, pulmonary disease, inflammation, diabetes and obesity, behavioral disorders and Alzheimer's disease.